GEOHEALTH HUB FOR RESEARCH AND TRAINING IN EASTERN AFRICA - U.S.

PROJECT SUMMARY/ABSTRACT
This application requests renewal of a progressive and tiered training program that equips researchers and
research teams with the skills to advance the occupational and environmental health research and translational
agenda in the linked U01 application (1/2: GEOHealth Hub for Research and Training in Eastern Africa –
Ethiopia). The trainees will be equipped to become regional research and training leaders and knowledgeable
in guiding policy. Building on successes and lessons from the current program, the proposed training and
research will advance translation of locally relevant scientific evidence around pressing issues in environmental
and occupational health, including climate change, into impactful actions. The training program will be
implemented in collaboration with Addis Ababa University (AAU) in Ethiopia, the Hub institution for the linked
application; the Spoke institutions are in Kenya (University of Nairobi) and Uganda (Makerere University).
Additional training partners will be in Rwanda, Ghana, and Cameroon further expanding the Hub's reach beyond
Eastern Africa, and longer-term plans will move toward more targeted expansion across sub-Saharan Africa.
The training program will build the competencies needed to address critical research themes emerging from
comprehensive Situational Analysis and Needs Assessments for these low- and middle-income countries: indoor
and outdoor air pollution, with a focus on children's and women's health; occupational health, specifically heat
exposure and worker productivity; and climate change. The U2R team includes experienced researchers and
educators from Columbia University, Colorado School of Public Health, Colorado State University, and the
University of Southern California who have records of collaboration with AAU and other partner institutions.
Tiered training activities will promote enhanced research capacity—creating national scientific leaders who can
advance research that addresses issues in occupational and environmental health—and skills in policy
translation, for national and regional contexts. In line with these goals and to ensure sustainability, the Hub and
Spoke institutions will assume leadership for locally developed training. The Hub Scholar program will continue
to use a flexible, cost-effective array of training modalities, including limited-length stays at Columbia University
and other US partner institutions; in-country MS- and PhD-level training with co-advising by US-based and
Eastern African mentors; in-country workshops and short courses; and synchronous and asynchronous distance-
based approaches. We also will continue to use innovative approaches to facilitate policy translation through
real-world engagement with stakeholders. Evaluation will track participants' success in meeting their
development goals in the short term and, in the longer term, in completing the proposed research, contributing
scientific presentations and papers, and attaining grant funding. Through careful case studies, we will continue
to examine the impact of trainees on policy indicators, such as implementation of new national air quality
standards and guidelines, regulations, and changes in practices.

Public health relevance
PROJECT NARRATIVE This renewal application proposes to continue a progressive and tiered training program that will further develop researchers and research teams able to carry out the research agenda of the Eastern Africa GEOHealth Hub and to facilitate the translation of the research findings into impactful actions by key stakeholders. The Hub will train 6 Hub Scholars (building on 11 Hub Scholars from the first funding cycle), degree level trainees (5 PhD and 12 MS/MPH degree candidates), research team trainees across the three LMIC primary partners, and additional trainees from stakeholders as well as three more training partner countries who are all expected to become national leaders in environmental and occupational health research. The Hub will continue to train multidisciplinary research teams, develop curricular materials for academic and stakeholder institutions, and foster evidence translation and implementation with a long-range goal of establishing a sustainable Hub for the region.